Investigating RNA dysregulation in Neurological Disease through study of Pontocerebellar Hypoplasia Type 1b

PROJECT SUMMARY/ABSTRACT
Pontocerebellar Hypoplasia Type 1b (PCH1b) is an autosomal recessive neurological disorder characterized by
hypoplasia/atrophy of the cerebellum and pons that is often fatal within the first year of life. The cerebellum and
pons integrate information from sensory systems, the spinal cord, and other parts of the brain to regulate motor
movements, breathing, and learning motor behavior. Individuals with PCH1b show muscle atrophy/weakness,
microcephaly, and developmental delay. Most individuals with PCH1b do not live past childhood and current
treatment is purely palliative. Mutations that cause PCH1b occur in the EXOSC3 gene, which encodes a
structural cap subunit of an evolutionarily conserved and ubiquitously expressed RNA processing complex, the
RNA exosome. The RNA exosome is a ribonuclease composed of both structural and catalytic subunits that play
a critical role in the post-transcriptional regulation of RNA. This complex is required for 3’ to 5’ processing and
degradation of a vast number of RNAs in both the nucleus and cytoplasm. Post-transcriptional processing of
RNA is a critical regulatory step in gene expression, as underscored by the number of neurological diseases
caused by defects in RNA processing factors. The tissue-specific phenotypes caused by the RNA exosome
complex are challenging to understand based on current models of RNA exosome function with only limited
analysis of the complex in any multicellular model in vivo. Thus, we aim to investigate the in vivo functional
consequences of distinct disease-causing amino acid substitutions in EXOSC3 that are linked to a range of mild
to severe phenotypes in PCH1b. We have generated an allelic series of EXOSC3 disease-linked missense
mutations in the Drosophila orthologue Rrp40 via CRISPR/Cas9 editing technology. Our previous work in flies
revealed an enhanced requirement for Rrp40 in neurons. Furthermore, our RNA-seq analysis of brain-enriched
transcriptomes of Rrp40 mutants revealed increases in steady-state levels of functionally important neuronal
transcripts, suggesting that disease-causing amino acid changes in the Drosophila RNA exosome subunit Rrp40
contribute to neuronal dysfunction. Our goal now is to characterize how disease-causing amino acid substitutions
in Rrp40 alter the molecular and cellular landscape of the developing nervous system in Drosophila in vivo. We
will test the hypothesis that the RNA exosome regulates RNAs that are critical for proper
neurodevelopment and function, a distinct subset of which are regulated by the RNA exosome cap
subunit Rrp40 (EXOSC3) through three complementary aims: 1) Assess the functional consequences of amino
acid substitutions in the Drosophila RNA exosome subunit Rrp40 corresponding to those that cause PCH1b; 2)
Interrogate how Rrp40 mutations affect expression and localization of key neuronal transcripts within the fly
brain; and 3) Exploit a genetic screen to determine whether aberrant accumulation of specific RNA exosome
targets disrupt fly development and/or homeostasis. Successful completion on these aims will provide a
synergistic understanding of RNA exosome biology and invaluable insights into PCH1b disease etiology.

Public health relevance
PROJECT NARRATIVE Pontocerebellar Hypoplasia Type 1b (PCH1b) is a devastating inherited neurological disorder that preferentially affects specific regions of the brain, the pons and the cerebellum, causing children born with this condition to have dramatically reduced lifespans. The mutations that cause PCH1b occur in a gene that encodes a critical component of a molecular machine that is important for the regulation of gene expression. The proposed studies exploit the fruit fly (Drosophila) as a model system to provide insight into molecular mechanisms underpinning PCH1b.